BLR&D Merit Review Research Career Scientist Award Application

As the general population and veterans age, their hearts will undergo dramatic changes that will reduce their
capacity to work efficiently and increase their susceptibility to injury. In addition, there are a number of co-­
morbidities such as diabetes that ensue with age that will further impact the heart and its adaptation to stress.
Interventions that help to protect the heart from injury are likely to be useful in patients at high risk for
cardiovascular events. Along with the general population, as veterans age, there will be an increasing burden
of healthcare associated with age that lead to cardiovascular dysfunction. There are a number of molecular
targets that may be critical in protection of the myocardium to stress but a unifying factor has been elusive, and
thus a pharmacologic target not well defined. It is possible that multiple pathways of stress adaptation share an
interconnected mediator that may be targeted therapeutically. The Patel Laboratory has been focused on
identifying novel and unique mediators that regulate a multitude of pathways and may therefore be viable
therapeutic endpoints for cardiovascular disease. The laboratory has a specific interest in caveolin and A-­
kinase interacting protein. There is clear clinical implication and need for interventions that limit the severity of
injury that occurs to the myocardium, as this is a major risk factor to morbidity and mortality. Interventions that
help to protect the heart are likely to be useful in many patients. Also, the basic nature of the studies underway
in the Patel Laboratory to understand the fundamental physiology of the cell may also be broadly applicable to
others organs and disease systems including but not limited to cancer biology, neurodegeneration, nephrology,
urology, muscle physiology, pulmonary diseases, and the biology of aging.

The Patel Laboratory has been specifically interested in assessing the impact of caveolae, membrane
microdomains enriched in lipids and the structural protein caveolin, on cardiac physiology and pathophysiology
for over a decade. Ongoing and collaborative studies with other national and international institutions has
resulted in expansion in multiple organ systems and the potential to translate basic findings to a number of
clinical problems. In 2004 Dr. Patel performed a very simple experiment where caveolae disruption showed
that both ischemia-­ and opioid-­induced cardiac protection was lost. This single experiment launched further
inquiry into defining the role of caveolae in the heart especially as it relates to disease pathology;; this was the
initial research funded by a Scientist Development Grant from the American Heart Association. The laboratory
has sustained and expanded this focus over the years to uncover fundamental biology to define the role of
caveolae in cardiac disease and develop tools to target this therapeutically. The Patel Laboratory has also
uncovered a specific, critical, and interconnected role of caveolin in regulating cellular metabolism that is being
applied to more complex studies related to neuroscience, cancer, diabetes, aging, and renal biology.

Public health relevance
As the general population and Veterans age, their hearts will undergo dramatic changes reducing their capacity to work efficiently and increase susceptibility to injury. Veterans also experience a number of diseases (i.e., diabetes, kidney failure, liver disease, etc.) that will all impact directly or secondarily to dysfunction in the heart. The research performed in the Patel Laboratory determines to understand novel mechanisms for stress adaptation in the heart. These mechanisms will allow identification therapeutics for heart disease to limit the morbidity and mortality linked to cardiovascular disease. There is clear clinical implication and need for interventions limiting severity of injury to the myocardium during stress in the setting of age. Interventions that help to protect the heart may be useful in patients undergoing surgery especially those at high risk for cardiovascular events. The research has the broad potential to impact healthy aging in the Veteran population in a number of areas including but not limited to cancer biology, neurodegeneration, and vascular biology.